ICAL: Impact of Cannabinoids Across Lifespan

Supplement Project Summary/Abstract Statement The original Project Summary/Abstract has not changed as a result of the proposed supplement activities.

Public health relevance
Supplement Project Narrative Statement The original Project Narrative has not changed as a result of the proposed supplement activities.